Center for Environmental and Health Effects of PFAS

Abstract
The NC State Center for Environmental and Health Effects of PFAS focuses on understanding the implications
of PFAS exposure in humans and animals in the Cape Fear River Basin of North Carolina. The Cape Fear River
in North Carolina is characterized by high levels of a variety of PFAS (per-and poly-fluoroalkyl substances)
throughout the watershed. The specific chemicals vary by location with the lower Cape Fear characterized by
the presence of novel fluoroethers from chemical manufacturing near Fayetteville, NC, while upstream, the levels
of legacy PFAS such as PFOA and PFOS are elevated and frequently exceed the drinking water advisory levels
for these chemicals. To better characterize the diversity of PFAS exposures among impacted communities along
the Cape Fear River, we have developed this supplement proposal to: 1) further characterize human exposure
in communities upriver from Fayetteville, 2) improve turnaround time for report back of PFAS blood results and
evaluate a self-administered method for PFAS blood testing, and 3) expand community engagement regarding
the recent National Academies of Sciences, Engineering, and Medicine recommendations for PFAS testing and
medical management for communities throughout the Cape Fear River Basin.

Public health relevance
Project Narrative PFAS (per-and poly-fluoroalkyl substances) are common contaminants of drinking water throughout the Cape Fear River Basin of North Carolina; the levels and types vary by region. This supplement will expand our current research project to continue to follow an additional PFAS exposed community (Pittsboro, NC); will enhance our ability to report PFAS results back in a timely fashion; and support community engagement about the recent National Academies of Sciences, Engineering and Medicine recommendations for medical management of PFAS exposed individuals.